Development of platforms for sorting, production, editing of beta cells

PROJECT SUMMARY
Patients suffering from type 1 diabetes must undergo burdensome, often lifelong, exogenous insulin
dependence. Up to now, the only available replacement therapy is to transplant islets from cadaveric donors.
However, such procedures present hurdles such as the scarcity of available donors and the rejection of
transplanted cells by the patient’s immune system. Also, over time, the transplanted islets tend to die. Several
types of stem cells, including embryonic stem cell and induced pluripotent stem cell, have been extensively
studied to generate glucose-responsive insulin-secreting cells and represents a more tenable source of islets.
However, a significant concern for transplantation therapy is the need for immunosuppressive drugs, which
exhibit long term side effects and hinders the feasibility of this approach to the large population of T1D patients.
Furthermore, cost-effective and large-scale production of these stem cell-derived beta cells is still a major
challenge. We propose to apply chemical biology and genome engineering approaches to develop platforms
for efficient sorting, production, and editing of these beta cells.
PHS 398/2590 (Rev. 06/09) 1 Continuation Format Page

Public health relevance
PROJECT NARRATIVE We aim to circumvent the current challenges of islet transplantation to boost therapeutic efficacy and achieve longterm treatment of Type 1 diabetes. Through harnessing principles of engineering, immune-isolation, and gene editing and chemical biology, we aim to demonstrate in vivo enhanced survival of islet grafts, reduced fibrosis, and prolonged glycemic control. PHS 398/2590 (Rev. 06/09) 1 Continuation Format Page